Core D: Metabolite Phenotypes of Aging

CORE D: METABOLITE PHENOTYPES OF AGING – PROJECT SUMMARY/ABSTRACT
Molecular genetic approaches have led to tremendous advances in the study of the basic biology of aging,
shedding light on the causes and consequences of senescence. But there remains a significant gap between
our ability to identify genetic and experimental perturbations that extend lifespan, and our understanding of the
mechanisms by which these perturbations extend lifespan. Metabolomics offers a relatively simple yet powerful
approach to close this gap. The metabolome consists of the thousands of unique small molecules that make up
the building blocks of all organisms, and its analysis has the potential to greatly enhance our ability to identify
and understand the functional pathways that underlie senescence. The primary goal of Core D is to assist
collaborating geroscientists in experimental design, sample collection and data analysis of accurate metabolite
profiles in studies on the basic biology of aging. The statistical support provided by the core has proven to be an
invaluable step in helping collaborators not only to obtain metabolomic data, but also to analyze the complex,
high-dimensional datasets that arise from metabolomic profiling. This Core will work closely with Core C (Protein
Phenotypes of Aging), which will be housed in the same facility, and with Core E (Invertebrate Longevity and
Healthspan). Cores C and D will collaborate with Core F (Artificial Intelligence and Bioinformatics) on a novel
project to develop metabolome-proteome networks for researchers interested in studying both domains
simultaneously. The resources offered here include methods that can be applied to a wide range of non-model
species, including humans. Core D will also play a key role in collaborative efforts between the University of
Washington NSC and other NSCs throughout the country. Core D has already collaborated with three Nathan
Shock centers (Albert Einstein, Oklahoma, and Alabama), and over 40 collaborating researchers around the
country. This Core will devote considerable effort to hardware and software development, ensuring that we are
constantly pushing the scientific boundaries in this field. The Core will also serve as a central repository for aging-
related metabolomic data. In the long term, Core D will help to make age-specific metabolite phenotypes an
essential and invaluable component of any study of aging phenotypes. The Core will have a major impact on
biogerontology at the broadest level, making these resources available to the broadest possible community of
geroscientists, and enabling our collaborators to identify new mechanistic pathways linking genes with aging,
including pathways that have the potential to reveal new drug targets.